Birefringence of the Lamina Cribrosa and Posterior Eye Structures

PROJECT SUMMARY
Glaucoma is the leading cause of irreversible blindness worldwide, and a majority of cases are undiagnosed.
Loss of vision due to glaucoma cannot be reversed, only slowed or halted. Therefore, it is imperative that damage
is detected and glaucoma is diagnosed early, so it can be managed and vision can be preserved. The most
common form of glaucoma presents with an elevated increase in intraocular pressure (IOP) with no known cause.
This elevated pressure causes gross anatomical changes to the posterior eye over time, such as optic disc
cupping. However, once the optic disc, or other structures in the posterior eye, has changed its structure, damage
has already occurred with the elevated IOP driving the increase in stress and structural alteration. Current
techniques for diagnosing glaucoma are woefully lacking in their sensitivity to minute structural changes in the
posterior eye. Optical coherence tomography (OCT) was developed to perform depth-resolved imaging of the
layers of the retina and optic nerve head with micrometer-scale resolution. However, the changes in the gross
anatomical structure and thickness of retinal layers imaged by OCT may also only be detectable after damage
has already occurred. It has been postulated that the difference between intracranial pressure (ICP) and IOP
may play a significant role in determining whether damage will occur in cases of elevated IOP. According to this
hypothesis, there should be a change in the stress distribution across the lamina cribrosa, signaling that stress
is too high and damage may be imminent. In cases where the translaminar pressure difference, and hence
imposed stress, is large, there may be a great risk of developing glaucoma. One method to detect small changes
in stress relies on the photoelastic effect, where the optical properties of a material, e.g., index of refraction and
birefringence, can change due to applied stress. The tissues in the posterior eye have notable birefringence, i.e.,
different optical properties corresponding to different orientations of light polarization and direction of
propagation, and OCT is capable of imaging the birefringence properties of tissues with its polarization-sensitive
functional extension. Therefore, this project proposes the development and application of a polarization-sensitive
swept source OCT (PS-SSOCT) system for 3D mapping of the birefringent properties of the posterior eye in a
non-human primate model. The PS-SSOCT system will be capable of micrometer-scale structural imaging and
mapping any minute changes to the tissue stress, driving changes in its birefringent properties induced by
changes in the IOP. Here, we propose exploratory in vivo non-human primate studies where the IOP is carefully
controlled and gradually stepped up and down, during which PS-SSOCT imaging will be performed. The local
distribution of the birefringence will be quantified in the retina, optic nervehead, and lamina cribrosa. The
birefringence will be correlated with the IOP and well-established metrics of the geometry of the posterior eye
based on the OCT structural image. The outcome of this research will lead to further in-depth research, including
human studies and additional animal studies correlating tissue damage to the IOP-ICP pressure difference,
which has significant implications for glaucoma diagnosis, therapy development, and disease management.

Public health relevance
PROJECT NARRATIVE Despite significant advances in understanding glaucoma, there is a lack of techniques that are able to detect minute changes in the tissues of the posterior eye driven by altered stress distribution due to elevated intraocular pressure before permanent damage to the sensitive nerves has occurred. To this end, here we propose the development and application of a polarization-sensitive swept source optical coherence tomography system for highly sensitive imaging of structural changes in the retina, optic nerve head, and lamina cribrosa that are not detectable by other means in a non-human primate model. The results of this work have a broad impact on early diagnosis and therapy planning for the most prevalent form of irreversible blindness worldwide.